Adapting and Testing a Novel Self-Compassion Intervention to Reduce Lung Cancer Stigma

Project Summary
Given advances in screening and treatment, the number of people in the U.S. living with lung cancer is
expected to increase by 25% (from 571,340 to 724,610) by 2030. Nearly all (95%) patients diagnosed with
lung cancer report experiencing stigma (i.e., the perception and internalization of negative appraisal from
others attributed to one’s lung cancer), which is perhaps the most prominent psychosocial issue in this
population and contributes to poor psychological and physical health outcomes. A critical gap in the field of
cancer control science is the lack of empirically supported patient-focused interventions that target the
reduction of lung cancer stigma for this growing patient population. The goals of this K99/R00 are to adapt the
existing Mindful Self-Compassion (MSC) psychosocial intervention to address anticipated delivery challenges
and target the reduction of lung cancer stigma as well as to seek preliminary evidence for the efficacy of the
adapted MSC intervention in reducing lung cancer stigma. The K99 study will involve a two-phase process of
1) conducting stakeholder focus groups to guide the iterative adaptation of MSC intervention activities and
materials and 2) conducting in-depth interviews with lung cancer patients to explore patients’ reactions to
intervention content and preferences for format and delivery. The R00 study will involve a two-phase process
of 1) conducting a pilot RCT (n=60) to test preliminary efficacy of the adapted MSC intervention on primary
(lung cancer stigma) and secondary outcomes (depressive symptoms, quality of life) and 2) conducting
interviews with purposively sampled high responders (n=10) and non-responders (n=10) from the MSC
condition (assessed post-intervention) to examine participants’ reactions to study participation. The overall
objective of this K99/R00 is to provide Dr. Williamson with additional training and mentorship to become an
independent cancer control investigator translating findings from basic behavioral scientific research into the
development of tailored psychosocial interventions for cancer patients. Training aims include: 1) Psychosocial
intervention development and adaptation in cancer; 2) advanced qualitative and mixed-methods design and
analysis; 3) translational psychological research (synergy between basic and applied health science); 4)
delivery of mindfulness- and compassion-based interventions in cancer care; and 5) professional
development. Dr. Williamson is mentored by Dr. Jamie Ostroff at Memorial Sloan Kettering Cancer Center
along with expert support from co-mentors (Drs. Lisa Carter-Harris and Jun Mao) and other significant
contributors (Dr. Christopher Germer, Ms. Kathleen Lynch), who are all committed to Dr. Williamson’s career
development. The proposed training plan will facilitate Dr. Williamson’s transition to independence as a
cancer control investigator conducting a programmatic line of research that 1) characterizes disease-specific
challenges of understudied cancer groups and 2) translates findings from basic behavioral research into
tailored psychosocial interventions that address such challenges and ultimately enhance quality of life.

Public health relevance
Project Narrative The number of people in the U.S. living with lung cancer is expected to increase by 25% (from 571,340 to 724,610) in the next decade, and the majority (95%) of lung cancer patients report experiencing lung cancer stigma (i.e., the perception and internalization of negative appraisal from others attributed to one’s lung cancer)—which is associated with adverse psychological and physical health outcomes. There is an urgent unmet public health need to develop psychosocial interventions to reduce lung cancer stigma and improve quality of life for this understudied cancer group. This project will fill a critical gap in the field of cancer control science by adapting an existing patient-focused, self-compassion intervention to target the unique, disease- specific issue of lung cancer stigma, address anticipated delivery challenges, and pilot test the efficacy of the adapted intervention on reducing stigma for lung cancer patients.